Machine Learning and Reflectance Confocal Microscopy for Biopsy-free Virtual Histology of Squamous Skin Neoplasms

Despite improvements in non-invasive medical imaging to aid in the diagnosis of internal malignancy,
improvements in imaging the skin non-invasively have been slower. The dermatoscope, a device that gives a
magnified and polarized view of the skin, is the only ancillary tool commonly used for clinical assessment by
dermatologists to assist in diagnosis. Keratinocyte carcinomas, basal cell carcinoma and squamous cell
carcinoma, are by far the most common cancers diagnosed in the United States. Due to sun exposure during
military deployment, our nation’s Veterans have an increased likelihood of developing these and other skin
cancers compared to the general population. Early keratinocyte carcinomas are often difficult to distinguish
clinically from irritated/inflamed precancerous or benign skin lesions (actinic or seborrheic keratoses). A non-
invasive technology that can assist dermatologists obtain a diagnosis of skin lesions may prevent unnecessary
biopsy, resulting in fewer scars, as well as allow diagnosis and definitive treatment of skin malignancies in the
same clinic visit, improving clinical workflow and patient access to dermatology clinics. A recently approved
skin imaging technology, reflectance confocal microscopy (RCM), provides state-of-the-art cellular level
resolution of the skin without biopsy, but still has many limitations, limiting its utility to only the most skilled
users. We recently began using software-based digital enhancements to autofluorescence of unstained frozen
tissue sections of microscopic slides to virtually stain unfixed tissue and provide rapid histology quality images
without requiring the laborious tissue processing required of actual processing. Our overarching hypothesis is
that we can apply our digital technology to overcome many of the technical limitations of RCM, and improve
the dermatologists’ or pathologist’s ability to obtain more accurate diagnosis of skin lesion by RCM without
requiring skin biopsy. Our preliminary data demonstrates that our software algorithms can digitally enhance
RCM images of normal skin and basal cell carcinoma, resulting in histologic quality images. In Aim 1, we will
use methodological and computational approaches to refine tissue processing and data acquisition to provide
optimal registration of skin images to obtain the highest quality data sets to train the machine learning
algorithm. In Aim 2, we will incorporate inflamed and uninflamed seborrheic keratosis, actinic keratoses, and
squamous cell carcinoma skin lesions to incorporate features of these lesions into our algorithms originally
developed for normal skin and basal cell carcinoma. In Aim 3, we will perform a pilot study to test the optimized
virtual histology algorithm by prospectively collecting images of consecutive skin lesions on a variety of patient
samples. We will compare how novice and expert RCM dermatology and pathology users perform in obtaining
diagnosis using RCM with and without the virtual histology algorithm. If successful, these studies will provide
an initial step towards noninvasive diagnosis of skin cancer for Veterans and civilians.

Public health relevance
During deployment, active military service members are exposed to sun for extended periods of time, and often have inadequate access to sun protection. Later in life, Veterans are predisposed to develop cancers of the skin’s epidermis. Thus, these cancers represent over 80% of malignancies plaguing our U.S. Veterans, and they often seek dermatologic evaluation for diagnosis of potential skin cancers. Currently, the diagnosis of these cancers relies on skin biopsy, which results in tissue processing and another clinical visit for definitive treatment if the biopsy is positive or an unnecessary scar if the biopsy is negative. The current proposal applies digital enhancement technology with state-of-the-art reflectance confocal microscopy to provide histology- grade images of skin to aid in the diagnosis of skin lesions without performing an invasive skin biopsy. If successful, the development of this technology may allow for future strategies to streamline Veteran dermatologic care and prevent unnecessary biopsies.